Spatiotemporal mapping of enhancer activity in developing frog embryos

Project Summary:
All cell types in an organism share the same basic genetic information, yet they execute remarkably
diverse gene expression programs and behaviors. Much of this diversity is derived from cell type-specific
and condition-specific usage of gene-distal regulatory regions known as cis-regulatory modules (CRMs)
(also known as enhancers). Typical mammalian genomes contain hundreds of thousands of CRMs
distributed across large genomic distances that act collectively and collaboratively to produce differential
gene expression patterns of extreme complexity. At present, our understanding of the biological roles of
most of these CRMs remains limited. For instance, how are specific CRMs selected to regulate a given
gene's expression? How do different CRMs coordinate and activate various target genes in a spatially
and temporally regulated manner? Our lack of understanding is in large part due to current limitations in
delivering simultaneous experimental measurements of the activities of large numbers of CRMs during
animal development. The major goal of this proposal is the successful use of Xenopus gastrula-stage
embryos as a model system for quantifying CRM activities involved in delivering precise spatiotemporal
expression patterns of target genes. While CRM activities are to be assayed at a genome-wide level,
their associated gene regulatory mechanisms would be determined with single-cell resolution. Applying
advanced computational biology algorithms to that data will deliver mapping of CRM activities sufficient
to infer the TFs and associated signaling processes involved in regulation of differential cell states in
gastrulae at single-cell resolution. We propose to address two specific aims. First, we will apply a modified
STARR-seq approach to identify CRMs that regulate spatiotemporal gene expression patterns in gastrula
embryos. We plan to mutate potential TF binding sites within CRMs to aid in identifying their biological
functions. Second, we will combine scRNA-seq with STARR-seq as a means of uncovering CRM-centric
gene regulatory structures critical for specifying cell states for every cell in gastrula-stage embryos. In
sum, we will use Xenopus tropicalis gastrula-stage embryos as the model system for generating a
system-level understanding of CRM activities in single cells because of the key phylogenetic position
amphibians occupy in the vertebrate evolutionary lineage. The approach proposed here would be much
more difficult to perform in mammals, because their embryos are not easily accessed for certain
necessary experimental manipulations, and because mammalian embryo availability is rate limiting for
some genomic work.

Public health relevance
Project Narrative Embryonic development requires the implementation of precise and intricate transcriptional regulation to provide the tight spatial and temporal expression of the hundreds to thousands of genes characteristic of any given cell type. While the various spatiotemporal gene expression patterns are orchestrated by cell type- and condition-specific enhancers, at present, our understanding of the biological rules by which the vast majority of these enhancers operate or how multiple CRMs converge to regulate even a single gene's expression remains limited. We will combine the experimental advantages of Xenopus with state-of-the-art, transcriptomic sequencing methods to accurately survey the global landscape of enhancer activity in the early embryo at single-cell resolution.